Conduct of studies to evaluate the toxic potential of thallium (I) sulfate in laboratory animals

The goal of this project is to provide support of the Division of the National Toxicology Program (DNTP) hazard identification activities targeted toward the prevention of diseases or adverse effects caused by environmental exposure to chemical or physical agents. Toxicity testing is an important aspect of public health research in that it serves to identify chemicals that are hazardous to human health. Proper conduct of toxicology studies is required to ensure that the resulting data are reliable. This project involves the conduct of toxicity studies of thallium (I) sulfate in rats and mice, following exposure in drinking water. This compound is found in drinking water and thus human exposure is anticipated via this route. In addition, thallium (I) sulfate is likely to be representative of other thallium compounds in drinking water. The data from this project will be used in the development of sound, scientific conclusions about the potential toxicity of thallium in rats and mice and ultimately supports the mission and goals of DNTP and risk assessment activities of other federal agencies. Keywords: toxicity, drinking water, thallium